Data-Driven Exploration of Exposomic Influences on the Onset of Alcohol Use During Adolescence

Project Summary/Abstract
Underage drinking in the US is a serious public health concern. Early onset of alcohol use (<15 years old),
increases the risk of developing alcohol use disorder by seven times compared to those who start drinking later.
Therefore, a comprehensive understanding of biopsychosocial factors associated with early alcohol use onset
in adolescence is crucial to address this problem. To this end, extensive studies have been conducted and have
identified genetic factors linked to future alcohol use, such as family history of alcoholism and higher polygenic
liability. The limited scope of genetic studies poses significant challenges including the (1) primary inclusion of
participants of European ancestry, (2) exclusion of those in the early stages of alcohol use, and (3) unclear
clinical applicability. This necessitates the need for exploring non-genetic environmental exposures (i.e.,
exposome) associated with alcohol use onset. As such, the proposed study aims to leverage data from the highly
powered and nationally diverse cohort, the Adolescent Brain Cognitive Development Study (ABCD; n = 11,000,
9-10-year-olds), and use a novel eXposome-Wide Association Studies (XWAS) approach to identify
exposomic risk factors and derive PolyeXposure Alcohol Risk Scores (PXARS) for alcohol use onset in
adolescents up to age 14. The performance of PXARS will be benchmarked against these established genetic
risk factors. Furthermore, the risk for alcohol use onset is linked to poor inhibitory control; thus, this proposed
project will comprehensively examine the neurobiological and behavioral correlates of prospective alcohol use
onset using data from the Stop Signal Task (SST). Studies also suggest that exposomic factors may influence
inhibitory control development; therefore, this study aims to uncover associations between neurobehavioral
factors, PXARS, and alcohol use onset. Unlike studying the genome, examining the exposome allows for
investigating the totality of the environment (i.e., natural, built, and social) to uncover potentially clinically
actionable targets. While many exposomic predictors may not be easily modifiable (e.g., racial biases,
socioeconomic barriers) but still warrant close examination; other predictors (e.g., peers, diet, and activities) may
be viable prevention and intervention targets for preventing and minimizing alcohol use in youth. The proposed
study offers the applicant a robust and comprehensive training program, which includes in-depth instruction on
big data and bioinformatics approaches, as well as task-based fMRI techniques and will significantly strengthen
the applicant's skillset. The applicant will receive exceptional support from a team of highly skilled sponsors and
consultants who have extensive experience in the fields of substance use neurobiology, exposomics, and
neuroimaging. Furthermore, the research will be conducted at the Icahn School of Medicine, a world-renowned
institution that offers top-tier training, coursework, and institutional resources including but not limited to the
Addiction Institute, the Institute for Exposomic Research, and the High-Performance Computing Core, making it
an ideal setting for executing the proposed study.

Public health relevance
Project Narrative The escalating rates of alcohol use among vulnerable youth populations necessitate a thorough understanding of how environmental factors shape risky decision-making, especially regarding alcohol use. This study proposes a novel multivariate approach that uses longitudinal data from the ABCD Study to calculate a polyexposure risk score and determine the role of inhibitory control in the risk for alcohol use onset in youth ages 10-14. The findings are expected to provide critical insights into the complex multidimensional features of youth at greater risk for early onset of alcohol use, and inform effective risk-mitigating strategies to reduce the prevalence of alcohol use among vulnerable youth populations.